PRISM BUSINESS AND REQUIREMENTS ANALYSIS SUPPORT

Business Analysis and Requirements Analysis:
The contractor shall perform an evaluation of current NIH and NHLBI acquisition processes and how they apply to the existing systems.